Cdk8 inhibition as a therapeutic intervention for ischemic fracture healing

Abstract:
Investigators: Christina Capobianco (PhD Student), Kurt Hankenson, DVM, MS, PhD (Sponsor), Tristan Maerz,
PhD, (Co-sponsor). Contributors : Annemarie Lang, PhD, Craig Duvall, PhD, Rhima Coleman, PhD.
Background: Nonunion fractures, defined by a failure to heal for greater than nine months are physically and
psychologically debilitating. Fractures accompanied by compromised or damaged vasculature are five times
more likely to go on to nonunion, resulting in decreased fracture callus formation accompanied by increased cell
death and fibrosis. Under ischemic fracture conditions, Cdk8 emerged as a top differentially upregulated gene
in the PDGFRɑ+ fibroblast population. CDK8 acts as a post-transcriptional mediator for various target genes,
including those of the HIF1ɑ and TGFβ signaling pathways, which are highly relevant to cartilage formation and
fracture biology. We demonstrated that inhibition of CDK8 improved fracture callus size and bone volume in
ischemic fractures in mice as well as chondrogenesis in human mesenchymal stem cells (hMSC), corroborating
its role as a negative regulator of chondrogenesis and presenting a therapeutic avenue to improve ischemic
fracture callus formation that has not yet been explored.
The central objective of this proposal is to establish the role of CDK8 in impaired chondrogenesis and to develop
a PDGFRɑ fibroblast-targeting nanoparticle to inhibit CDK8 in the fibroblasts that are bone and cartilage
progenitors, promoting chondrogenesis in the context of ischemic fracture healing.
Specific Aims: Aim 1) Characterize the impact of CDK8 on chondrogenic differentiation; Aim 2) Demonstrate that
PDGFRɑ+ fibroblast-targeting nanoparticles delivering a CDK8 inhibitor improve ischemic fracture healing.
Research Plan: Aim 1) The effect of CDK8 on chondrogenesis will be evaluated through CDK8 gain and loss of
function in hMSC chondrogenic pellets. Proteomic analysis and bulk RNA sequencing of the pellets will identify
alterations in HIF1a and TGFβ signaling pathways as well as permit an unbiased assessment of alternative
mechanisms of action that may be occurring via CDK8. CDK8 overexpression and inhibition will be performed
in a fracture hematoma model and chondrogenic genes as well as those shown to be perturbed in hMSC will be
analyzed via RT-qPCR and immunofluorescent staining. Aim 2) We will fabricate and characterize a PDGFRɑ-
antibody bound nanoparticle encapsulating the Cdk8 inhibitor SNX631. C57 Bl/6 mice will receive the SNX631-
PDGFRɑ nanoparticle at time of ischemic fracture to assess the effect of targeted and sustained Cdk8 inhibition
on ischemic fracture callus formation. To demonstrate translatability to human cells, hMSC pellets will be treated
with the nanoparticles and expression of chondrogenic markers will be assessed.
Conclusion: Completion of the proposed aims will lead to better understanding of CDK8’s role in chondrogenesis
and advancement of therapeutic treatment for ischemic fracture patients to improve their quality of life.

Public health relevance
PROJECT NARRATIVE Almost half of all long bone fractures with accompanying ischemic complications or vasculature damage fail to heal, leading to severe pain and significantly reduced quality of life, emphasizing the critical need for therapeutic interventions to improve ischemic fracture healing for affected individuals. Establishment of a robust cartilaginous callus is necessary for proper long bone fracture repair and our preliminary evidence indicates that overexpression of Cdk8 under ischemic conditions could impair this necessary process. This study aims to leverage our previous findings to characterize the role of Cdk8 in chondrogenesis and implement a targeted therapeutic intervention to enhance ischemic fracture repair and bone regeneration.